Reproductive Hormones - Biological and Molecular Actions

PROJECT SUMMARY
Advancing our mechanistic understanding of androgen-dependent male reproductive function requires an in-
depth structural understanding of the core transcriptional complex in which ligand-occupied androgen receptor
(AR) in complex with steroid receptor coactivator-2 (SRC-2) and p300 enacts transcriptional initiation of
specific androgen-responsive gene expression programs. Until recently, structural information on the
assembly modes by which the nuclear receptor (NR) engages with primary and secondary coregulators
(Coregs) was limited to studies based on NR and Coreg protein fragments, which provided a significantly
incomplete and, in many cases, an erroneous perspective of NR/Coreg transcriptional complex formation. To
address this limitation, my team recently used cryogenic electron microscopy (cryo-EM) and proteomics to
solve the quaternary structure of a number of NR/Coreg transcriptional complexes related to cancer biology at
a full-length structural level. Apart from providing essential insights into the structure and assembly
mechanisms of these core transcriptional complexes, an important “take away” from these investigations was
that the structure and stoichiometry of the transcriptional complex for one NR cannot be extrapolated to explain
the structure of another NR, despite sharing a similar functional domain organization. With this mind, Specific
Aim 1 studies will use breakthrough advances in cryo-EM to obtain the quaternary structure of the DNA-bound
liganded AR dimer in complex with SRC-2 and p300. Advancing the applicability of cryo-EM further, structural
investigations in Specific Aim 1 will also solve the 3-dimensional structure of the core AR/Coreg
transcriptional assembly in complex with the nucleosome core particle, the next level of structural complexity to
be studied if we are to significantly advance our understanding of AR-mediated transcriptional initiation in the
context of chromatin. Studies in Specific Aim 2 will apply cryo-EM to determine the structure of an AR(N727K)
transactivation mutant as an approach to elucidate (at a full-length structural level) the importance of allostery
within the AR dimeric complex in N- and C-terminal cooperativity, a prerequisite for Coreg recruitment and
transcriptional activation. The structural studies in Specific Aims 1 and 2 will be functionally complemented in
Specific Aim 3 by versatile cell-free assays of AR or AR(N727K)/Coreg-mediated in vitro transcription and
enhancer-promoter crosstalk at an AR target gene at the proteome level. Providing in vivo support for findings
from Specific Aims 1-3, a uniquely engineered AR point mutant mouse in Specific Aim 4 will be phenotyped
at the histological, cellular and molecular level to define the importance of AR N/C terminal domain
cooperativity in male reproduction, in particular spermatogenesis. Collectively, our studies will furnish a
structural, functional and physiological basis for AR-mediated transcription in the maintenance of male
reproductive function. In keeping with NICHD priority goals, outcomes from these studies will also provide a
conceptual framework for understanding abnormal responses to androgen that lead to androgen insensitivity.

Public health relevance
PROJECT NARRATIVE This research will define the structural, molecular, and cellular mechanisms by which the hormone-bound androgen receptor, in complex with the steroid receptor coactivator-2, transcriptionally controls gene expression programs that promote and maintain normal male reproductive processes. Breakthrough advances in cryo-electron microscopy in tandem with studies using in vitro transcription/proteomic assays and innovative engineered mouse models will uncover the indispensability of the androgen receptor/steroid receptor coactivator-2 transcriptional complex in regulating androgen-dependent gene expression. Therefore, research findings from these studies will markedly improve our current knowledge not only of androgen control of male reproductive biology but also androgen insensitivity that can lead to infertility and other male-associated reproductive morbidities.